Single Visit Clinical Validation of ScreenFire, a Low-Cost HPV Test: Efficacy and Cost Effectiveness (SCALE)

PROJECT SUMMARY/ABSTRACT
In 2018, the World Health Organization (WHO) called for action towards achieving the global elimination of
cervical cancer. A strategy for achieving this goal was ratified by member states in August 2020. The WHO
plan calls for an aggressive approach of vaccination, screening, and treatment of the human papillomavirus
(HPV), the single cause of cervical cancer. In low- and middle-income countries (LMIC), which bear 90% of the
incidence and mortality of cervical cancer globally, it is estimated that these goals will not be reached until
2120 – a century from now. One way to markedly shorten this timeline is through HPV self-sampling and
immediate treatment for those who screen positive. In order to scale-up HPV there must be a low-cost,
effective test that is easy to use in the field. An optimal field test would allow women to collect their own
samples without compromising efficacy. The only WHO prequalified test specifically developed for low
resource settings is careHPV, which has relatively good sensitivity when a sample is taken by a clinician, but
which performs poorly when self-sampled. There is an urgent need for evaluation of a low-cost self-
sampling test that is effective and can be easily implemented in LMIC. AmpFire® (Atila Biosystems, CA),
a new low-cost HPV test, has demonstrated high sensitivity in self-collected samples and may perform better
than provider-collected careHPV. Furthermore, the current protocol for careHPV requires a 2-day visit because
the machines are in a central location and require 3-4 hours for processing. AmpFire® can be run from local
locations using a battery-operated PCR machine. Since these tests process in approximately 1 hour, a single-
visit approach is feasible, which is more efficient for the health system and more convenient for patients. The
purpose of this study is to compare the efficacy of AmpFire® versus careHPV for the detection of high grade
precancer (cervical intraepithelial neoplasia, grade 2 or higher, or CIN2+) and to compare the efficacy and
feasibility of each test through the following aims: Aim 1: To compare self-collected AmpFire® to standard
provider-collected careHPV for the detection of high grade cervical precancer. Aim 2: Demonstrate
that a single-visit approach using self-collected AmpFire® will result in lower loss to follow-up than the
current conventional two-visit approach using provider-collected careHPV. Aim 3: Perform a cost-
effectiveness analysis to compare efficacy, loss to follow-up and generalizability of self-sampled
AmpFire® HPV versus provider-collected careHPV.

Public health relevance
Project Narrative The World Health Organization (WHO) recently launched a Call to Action to eliminate cervical cancer by 2030, with aggressive goals for vaccination, screening, and treatment. To scale-up screening, there must be a low-cost, effective test for the human papillomavirus (HPV) that allows women to collect their own samples and returns results the same day to treat those who screen positive. The current research will show that self- collection of AmpFire®, a new affordable test for HPV, will be superior in efficacy to the current test used in low-resource settings, allow for a single-visit approach to decrease loss to follow-up, and provide a cost- effective approach that aids in the effort to eliminate cervical cancer.